A&R FHSU

PROJECT ABSTRACT
Renovated, functional research space is imperative for continued growth and excellence in IDeA State
universities. Here, the K-INBRE puts forth an application from a valued, primarily undergraduate institution (PUI)
requesting updates and renovations in 5 rooms in two buildings on the Fort Hays State University (FHSU)
campus. The K-INBRE is requesting $250,000 to assist FHSU in upgrading its facilities in five locations on the
FHSU campus, increasing its capacity to conduct biomedical research. Renovations will improve two spaces in
Albertson Hall (AH166 and AH 347) to create two modern, functional research spaces. Plans include updating
the single microbiology research laboratory in Albertson Hall by adding custom casework for storage, updating
electrical and plumbing to add drop-in sinks, and installing an ice maker. Additional updates will renovate the
anatomy and physiology laboratory used by students in upper-level anatomy and allied health programs for
research projects associated with joint and spine dysfunction. Renovations in Tomanek Hall (TH) will convert the
current storage space to repurpose it to house NMR instrumentation associated with the Chemistry Department.
Renovations will install cabinetry and equipment to house the computer system accompanied by the instrument
in TH119. The installation will require electrical and compressed air systems to be rerouted into the room. A
liquid nitrogen generation system will be installed to support K-INBRE researchers. Renovations in TH303
request installing new casework to secure purchased research equipment. Improvements in TH307 will install a
Combination Glove Box to improve the safety of handling toxic and dangerous chemicals. The renovations
include a supporting base, a vacuum pump for evacuating, and inert gas for filling. FHSU is a valued K-INBRE
network partner that continues growing its footprint in PUI faculty and student research. These renovations will
add to the strong institutional commitment to increase and improve the existing biomedical research initiatives
on the FHSU campus.